Mechanisms that regulate microglial dynamics in the context of plasticity

Project Summary
We will use the funds in this supplement to support the further training of trainees in the
laboratory.

Public health relevance
Project Narrative We will use the funds in this supplement to support the further training of trainees in the laboratory.